Advancement of an Impending Hospitalization Detection Platform

Abstract
Heart, Lung, Blood, and Sleep (HLBS) conditions such as heart failure, COPD, and pneumonia are among the
most common causes of hospitalizations. Many of such hospitalizations are thought to be avoidable with early
recognition and intervention. Today, patient-reported symptoms represent the primary means of detecting
impending hospitalizations, but because symptoms are late indicators of disease, this results in days to weeks
of delay in receiving care. We developed a non-contact adherence-independent longitudinal bed-sensing
platform to detect early physiologic signs of impending hospitalizations before patients recognize or self-report
symptoms. Preliminary results from our bed-based mechanical sensors suggest that the technology can learn
patient-specific baselines during clinical stability and can recognize excursions from baseline in the early
stages of developing illness. Here, we propose a milestone-based project aimed at collecting human training
datasets and developing generalizable models that can recognize impending hospitalizations in the home with
a focus on the underrepresented populations of San Diego and Imperial Valley counties. We now propose a
administrative supplement to explore its ability to detect ventricular ectopy and arrhythmias. Doing so will
encourage utilization and adoption across HLBS disease verticals and patient subpopulations.

Public health relevance
PROJECT NARRATIVE The goal of this study is to advance a bed sensing technology platform through real-world patient testing. Doing so will improve our ability to recognize the earliest signs of impending hospitalizations in high-risk patients, days to weeks before symptoms are self-recognized and self-reported.